Center for Biologic Basis of Oral/Systemic Diseases (CB*

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To implement an intervention trial to effectively improve oral health in the GDM women with "at-risk" pregnancies and lower the risk of adverse pregnancy outcomes.